Administrative Core

ADMINISTRATIVE CORE PROJECT SUMMARY
The Leadership Administrative Core (Core A) will provide scientific, administrative, fiscal, and organizational
coordination of all the activities of the Projects and Cores to ensure this Program Project Grant (PPG) meets all
of the proposed scientific goals. This will be achieved by providing an organized infrastructure to: 1) streamline
effective communications internal and external to the Program (e.g., annual reporting and publications), and
promote synergistic collaborations among the three Projects, the Resource Sharing Core, and selection of
external collaborative projects (i.e., distribution of collaborative funds), 2) perform fiscal management and
administration, 3) provide annual and mid-point evaluation to stimulate progress towards accomplishing the
overall scientific goals of the U54 Program, 4) ensure research is conducted under the highest ethical and
scientific standards. Our Program represents a multidisciplinary team of NCI-funded “organ-specific” bladder
cancer investigators within Cedars-Sinai Medical Center to investigate the stromal microenvironment as a co-
organizer of bladder carcinogenesis and progression.